3D carbon-nanotubes integrated microdevice for extracellular vesicle isolation and in situ sample preparation towards noninvasive pancreatic cancer diagnosis

PROJECT SUMMARY
Pancreatic cancer is the deadliest solid malignancy with an abysmal overall 5-year survival less than 7%. Late
stage diagnosis is regarded as the most important factor contributing to the bleak patient outcome. Since
pancreatic neoplastic cells can take decades to metastasis, in theory, there is a large window for early diagnosis.
However, current early diagnosis often fails due to lack of sensitive and specific pancreatic biomarkers and
limitations on the spatial resolution of the imaging methods. Extracellular vesicles (EVs) are sub-micrometer
vesicles released by almost all the cells and are emerging as an attractive non-invasive liquid biopsy target for
clinical cancer diagnosis. Compared with other liquid biopsy materials, EVs are likely released by live cells and
contains much longer DNA fragments than circulating tumor DNA (ctDNA), and are more abundant than
circulating tumor cells (CTCs) to provide higher sensitivity and better clinical utility. Based on our preliminary
study on using carbon nanotube (CNT) forest as an unprecedented material for sub-micrometer particle isolation,
we propose a new CNT-integrated EV isolation and genome enrichment microdevice (CNT-iEVIGEM), which is
a continuous flow microfluidic device integrated with CNT forest. The self-regulating continuous-flow design
boosts the sample capacity and throughput of our previous CNT integrated device by 10 times and eliminates
clogging, while making the device immune to local CNT forest defects and maintaining high EV capture efficiency.
With additive fabrication of nanometer-thick functional zirconia on CNTs, the CNT-iEVIGEM can efficiently purify
EV DNA in situ. For pancreatic cancer diagnosis, we will develop a multiplex digital droplet PCR (ddPCR) assay
to detect KRAS mutations from EVs isolated from plasma by CNT-iEVIGEM. KRAS mutations are the most
prevalent pancreatic cancer mutations with over 90% occurrence. It is a major driver oncogene and often the
earliest event in pancreatic tumorigenesis. Using model samples of cancer-derived EVs spiked in healthy control
plasma, we will determine the detection limit as the lowest mutant allele fraction that can be detected
unambiguously. The assay will be validated with 75 plasma samples from stage IV pancreatic cancer patients
and 75 age-/sex- matched healthy donors. Then we will use this assay to investigate diagnosis of pancreatic
cancer at different stages, by recruiting 60 early stage (stage I + II) and 60 stage III pancreatic cancer patients.
The sensitivity and specificity of the assay at different stages will be measured with the mutation status in tissue
samples as the true values. The proposed study will pave the way for further clinical validation of the CNT-
iEVIGEM technology for cancer diagnosis. The EV isolation platform can also be used for other DNA mutations,
other EV cargos, and other cancer types as a non-invasive liquid biopsy technology.

Public health relevance
PROJECT NARRATIVE Pancreatic cancer is the deadliest solid cancer and early diagnosis is believed to be the key to significantly improve patient survival. In this proposed study, we will develop a nanomaterial integrated microfluidic device to isolate extracellular vesicles from patient plasma and perform on- chip sample preparation to extract DNA from these vesicles. We will use it as a platform to develop a sensitive mutation detection assay for non-invasive early diagnosis of pancreatic cancer.